Data Management Administrative Supplement for grant R01AA030548

PROJECT ABSTRACT
This application requests an administrative supplement to support data submission activities required by the
National Institute of Mental Health (NIMH) National Data Archive (NDA) for our ongoing study. The initial parent
project (R01AA030548) budget did not include a line item for costs related to data reporting requirements. The
funding requested in the proposed supplement is based off amounts calculated using the NDA Data
Submission Cost Estimation Tool. The proposed supplement will enable substantial additions and adjustments
to the study's data management processes to comply with NDA reporting standards. Specifically, these
changes include the establishment of a dedicated Data Manager position to oversee GUID creation and ensure
adherence to the NDA Data Dictionary Templates. The Project Manager will integrate NDA reporting into study
workflows, manage submission timelines, and align IRB consent language with NDA requirements. The
Principal Investigator will provide scientific oversight and training related to data submission processes.
Additionally, the supplement will cover mandatory costs associated with UNC’s Research Data Management
Core (RDMC) to ensure compliance with data management and sharing policies. These updates will ensure
accurate, timely, and high-quality data submissions to the NDA. We note that the research aims have not
changed and will remain the same as in the funded proposal. The additional costs requested are to support
data reporting requirements and do not represent a change to the research scope.

Public health relevance
Project Narrative Alcohol consumption is a leading cause of death and disability in the United States. Requiring evidence-based health warnings on alcohol containers could inform consumers and reduce unhealthy alcohol consumption, but there is little data on how such warnings influence alcohol consumption. The proposed research will optimize evidence-based warnings about the health harms of alcohol consumption and evaluate their effectiveness at reducing alcohol consumption among regular alcohol consumers in the US.